Installation of a reverse osmosis water treatment system in LAR

Project Summary/Abstract:
The tap water at Wright State University (WSU) has a history of contaminants present to include
lead, high salt levels, and other known and unknown contaminants. The Ohio EPA confirmed
that the aquifer that supplies water to WSU is particularly susceptible to contamination due to
physical factors such as depth and lack of a confining layer. Though the potable water at WSU
meets EPA requirements for human consumption, a number of principal investigators believe
the water is jeopardizing their laboratory animal research results. This proposal is to fund the
purchase and installation of a water treatment system to provide drinking water to all research
animals in the WSU Laboratory Animal Resources (LAR) vivarium. The water treatment system
will include a water softener, reverse osmosis (RO) system, and a water bottle filling station.
Pretreatment of water with a water softener is necessary due to high water hardness, which
decreases the lifespan of RO system filters. After pretreatment, the RO system will remove 99%
of contaminants from water and acidify it to prevent bacterial growth and biofilm formation.
Acidified water will be piped to a water bottle filling station capable of filling up to 49 bottles
simultaneously in less than 10 seconds, a significant operational efficiency. A pH meter is
necessary to complete daily quality assurance checks of the system. The water softener and
RO water treatment system will be in continual operation with processed water stored in a 485
liter storage tank. The bottle filling station will be used to fill approximately 1,200 bottles to be
used for research animal drinking water each week. Properly maintained, this water treatment
system will remain in operation and continue to benefit the WSU biomedical research program
for up to 15 years, and the bottle filler will last for 20 or more years before replacement is
necessary.

Public health relevance
Project Narrative: The provision of potable, uncontaminated drinking water to animals used in research is required to preserve animal well-being and improve the quality of research at Wright State University. Contaminants may serve as variables that have the potential to impact experimental outcome. The integrity of research findings is critical in the practice of evidence-based medicine, therefore the installation of a water treatment system to ensure contaminant-free drinking water for research animals will not only protect animals, it will also protect public health.